Atlanta Network for Training In KUH Scientific Research (ATLANTIS)

The ATLANTIS Network Core is structured to optimize Kidney, Urology, and Hematology (KUH) focused
research trainee success through technologically innovative and purposeful networking and interactions. A newly
created digital platform named ATLANTIS-Connect will be designed as a centralized hub to bring together a
community of established, emerging, and future KUH health researchers from Emory, Georgia Tech, Morehouse
School of Medicine, and the Atlanta metro region, including from the local Historically Black Colleges and
Universities (HBCU). Our goal is to establish an environment conducive to cultivating a scientific community that
is able to effectively network, communicate, and collaborate across a variety of scientific settings using modern
communication tools. We will accomplish this goal through three specific aims. The first aim will develop and
maintain a peer network providing an open forum for all trainees to interact, exchange ideas, and troubleshoot
scientific and professional issues. We will accomplish this through the deployment of the newly created digital
platform designed to foster peer and near-peer communication and provide opportunities for effective peer, near-
peer, and cascading mentorship experiences. The environment we will build will promote trainee-led production
of shared content and resources and will engage emerging KUH scientists in an innovative way designed to self-
sustain the ATLANTIS peer network. In the second aim, we will promote inter-disciplinary collaborations and
team science through existing events and newly planned activities by leveraging these existing and new
platforms to cultivate interest and increase visibility to KUH-mission focused research. The environment fostered
through these actions will support networked research communities thus presenting unique opportunities to
pursue novel research projects addressing KUH-mission areas using design-thinking approaches. For the third
aim, we will foster a robust research pipeline by developing community outreach programs to increase early
exposure to biomedical careers in KUH disciplines to high school and undergraduate students and promote
KUH-related research opportunities to trainees in undergraduate, graduate, medical school, and residency
programs. We will also invite emerging and aspiring scientists from diverse career pathways and backgrounds
at partner institutions, including through existing partnerships with Atlanta-area HBCU, to engage in ATLANTIS-
Connect thus providing them with support, near-peer mentoring, and career development resources. Trainees
in the ATLANTIS network will also serve as ambassadors to promote the merits and value of our networked
learning communities to peers in their training programs. Through these aims and objectives, the proposed
ATLANTIS Network Core will enhance engagement and training experience for KUH researchers across the
educational spectrum (high school to junior faculty). This will result in KUH trainees being better equipped to
collaborate, publish, communicate, and succeed in research-intensive and research-related careers, which will
be key to achieving success in growing this scientific workforce in generations to come.

Public health relevance
Atlanta Network for Training in KUH Scientific Research (ATLANTIS) is an Institutional Network Award for Promoting Kidney, Urologic, and Hematologic Research Training in Atlanta. Our goal is to create an institutional resource for training the next generation of researchers for the study of kidney, urology, and hematologic (KUH) diseases. ATLANTIS will bring together trainees at multiple career stages who are interested in furthering their scientific research training and pursuing a career in biomedical research.